Improvement of Overall recruitment, Latino Community Outreach and MRI acquisition

Project Summary/Abstract:
During the progression of our study, we identified important deficiencies in our scientific plans and
made necessary adjustments as quickly as possible. These deficiencies included overall patient
recruitment, Hispanic patient outreach and inadequate supervision of our complex MRI data
acquisition. As detailed below, we made highly needed adjustments. Overtime these changes will
result in deficits that will prevent us from completing our proposed work to our high standard. We
have defined an aim to address each issue and described in detail the problem and how we have
addressed it.
Value added and the Relation and Scope of Supplement and Parent Aims: This supplemental
award promotes the high quality and success of our science by addressing unexpected problems
using simple but imperative changes. As noted, we have implemented the needed changes
already, but do not have the budget to adequately cover these costs. Beyond this, we have also
started towards an important path of Hispanic community outreach that will benefit the Hispanic
community and our current and future projects.

Public health relevance
Supplemental Project for NIA R01AG070987 Improvement of Overall recruitment, Latino Community Outreach and MRI acquisition Project Narrative The primary goal of this supplement is to improve Hispanic patient outreach. This will improve patient recruitment, establish good relations to maintain outreach for this and future studies, and it will help underserved Hispanics in Southern Arizona have better vascular care access. We will also improve homogeneity and quality of MRI acquisition.